Core A: Administrative

ABSTRACT – ADMINISTRATIVE CORE A
The overarching goal of the Administrative Core is to provide the operational support necessary to meet the
goals of each Project and the overall Program Project Grant (PPG) “Precision Interception of Gastric Cancer
Precursors Through Molecular and Cellular Risk Stratification.” This core will support the ultimate mission
of the PPG which is to develop precision medicine strategies for preventing gastric cancer. The Core will function
as the organizational hub for the PPG, centralizing resources to maximize efficiency for the three Projects. The
five major objectives of the Core are:
(1) Managing the finances of the PPG and allocating specific funds to each Project.
(2) Communicating with all appropriate regulatory entities.
(3) Coordinating translational activities and clinical trial efforts.
(4) Monitoring progress and facilitating interactions across Projects, Cores, and Advisory Boards.
(5) Ensuring timely data and resource sharing.
The Core will contribute fiscal management and oversight to the PPG through the efforts of multidisciplinary
personnel with expertise in these distinct responsibilities. It will provide coordinated and consistent
communication with all regulatory entities to ensure proper research conduct. Frequent PPG review meetings
will also be facilitated by the Core. The Core Leads will serve as liaisons with Divisional and Departmental
personnel to enhance interprofessional collaboration and advance discoveries. All Projects and Shared
Resource Cores will utilize the functions of this Administrative Core. As a result, the Core's work will contribute
to the overarching theme of intercepting and developing precision cancer prevention of gastric cancer.

Public health relevance
NARRATIVE – ADMINISTRATIVE CORE A The objective of the Project Program Grant (PPG) is to improve precision cancer prevention for patients with a high likelihood of developing gastric malignancies. To achieve this goal, the PPG will rely on a centralized operational, fiscal and regulatory support system. Core A will streamline managing the administrative components of the research program and enables the PPG to be successful in achieving its goal of improving prevention of stomach cancer.